Mitochondrial influences on blood brain barrier function and neuropsychiatric illness

Summary
Neuroinflammatory processes are increasingly associated with neuropsychiatric disorders and diseases. The
blood-brain barrier (BBB) is a critical modulator of peripheral inflammatory influences on brain development and
function. Co-PIs Jorge Alvarez, a neuroimmunologist with expertise in the BBB, and Stewart Anderson, a
developmental neurobiologist with expertise in mechanisms of neuropsychiatric disorders, have recently
demonstrated that the BBB is compromised in a relatively common genetic cause of neuropsychiatric illness, the
22q11.2 deletion syndrome (22qDS). While this finding in induced pluripotent stem cell (iPSC)-derived BBB-like
cells (iBBB) and in 22qDS mice was initially ascribed at least partially to haploinsufficiency of the BBB-enriched
tight junction protein claudin-5, work from the Anderson lab and others has also demonstrated that 22qDS is
associated with mitochondrial energetic compromise in various cell types. Since mitochondrial energetics are
also necessary for optimal BBB function, the PIs initiated experiments to determine whether mitochondrial
energetics of the BBB are compromised in 22qDS, whether this compromise is likely to influence BBB
dysfunction in this disorder, and whether correction of mitochondrial weakness improves BBB dysfunction in
22qDS. Remarkably, our preliminary data suggest that the answer to all three possibilities is yes.
Here, we propose to study the synergistic influences of structural and energetic compromise on BBB
function. As we have previously found in iPSC-derived neurons and transformed blood cells that the presence
of 22qDS with schizophrenia (SZ) is associated with weaker mitochondrial energetics than 22qDS without SZ or
non-deleted controls, in Aim 1 we will assess whether this association of mitochondrial weakness and the
presence of SZ in 22qDS extends to iBBB cells. We will also examine whether interventions that enhance
mitochondrial energetics improve BBB function, both in the 22qDS iBBB, and in 22qDS model mice. In Aim 2
we will use the more reduced system of mice heterozygous only for claudin-5, and selectively in the BBB, that
have been shown to have a moderate neurovascular deficit. We will test whether crosses of these mice with
those lacking the mitochondrial-DNA encoded gene ND6 will have exacerbated BBB dysfunction relative to each
mutation alone. We will also test whether enhancing mitochondrial energetics pharmacologically will rectify BBB
dysfunction in the neurovascular selective claudin-5 +/- mice.
In sum, the mitochondrial influence on BBB function is an underexplored area of study. Since these
influences are therapeutically targetable and since the BBB's influence on neuroinflammation and brain health
is increasingly appreciated, this proposal could lead to important novel therapeutics both within and beyond the
22qDS context.

Public health relevance
Narrative Both mitochondrial and blood brain barrier (BBB) dysfunction have been independently associated with neuropsychiatric illness. Based on our recent publications and compelling preliminary data, we propose that in a relatively common genetic cause of neuropsychiatric illness, mitochondrial dysfunction contributes to BBB dysfunction and presents a novel therapeutic target. If our hypothesis is correct, this finding can shift paradigms for inflammatory influences on brain development and function based on the synergistic influences of relatively subtle structural and energetic weaknesses in the BBB.